Displayed social media references to sobriety, abstinence and moderation (SAM): Prevalence, predictors and possibilities

PROJECT SUMMARY/ABSTRACT
Young adulthood is a critical time period in which alcohol use is common and consequential. Social media has
emerged as a novel research tool to understand alcohol cognitions and behavior in this age group. The vast
majority of young adults use social media, and studies have illustrated that alcohol posts are frequent and have
positive associations with alcohol behavior. Previous studies have focused on two types of alcohol posts on
social media: general alcohol use and intoxication/problem drinking. This study proposes to focus on a novel
type of social media message, posts promoting safety, abstinence or moderation (SAM). Our previous study of
college students found that SAM posts represented less than 1% of all alcohol posts; however, our newer R34
study of community college students found approximately 5% of alcohol posts represented SAM. There are two
unique possibilities for SAM posts; one is that they may influence social norms about alcohol use via social
media’s broad reach and influence. Second is these posts may be displayed by individuals who are considering
behavior change, an ideal population for targeted interventions. To date, no studies have examined the
prevalence, content and meaning of SAM posts across a diverse population of young adults. Our over-arching
goal is to use social media to identify problem alcohol use in young adults and provide feasible, scalable and
targeted interventions. We have pursued this goal over the past decade, including a recently completed NIAAA-
funded R34 (MPIs Moreno and Lewis, R34AA025159) to identity at-risk community college students using
Facebook and Instagram and provide a validated web-BASICS intervention. This R21 proposal would advance
the field by understanding the frequency and meaning of SAM posts. We will utilize Qualtrics to recruit a diverse
young adult sample (n=300). Eligible participants will maintain at least one social media profile from among
profiles with high identity affordances, including Instagram, Twitter and Facebook. After obtaining consent and
completion of an online survey, we will link to up to three of participants’ social media profiles. For Aim 1, we will
use content analysis to evaluate up to 3 social media profiles over one year for each participant. Coders will
evaluate displayed alcohol posts and SAM posts. Aim 2: We will use Qualtrics survey data from all participants
to assess how alcohol and SAM posts are associated with protective behavior strategies, alcohol behavior and
social norms. Aim 3: After Aims 1 and 2 analyses are complete, we will select 25 participants who displayed
SAM posts and conduct cognitive interviews to understand how they perceive SAM posts. Consistent with the
R21 mechanism, this study would provide fundamental knowledge to understand the frequency and meaning of
SAM posts. The outcomes of this innovative study will inform novel opportunities for social media messaging,
big data surveillance approaches and tailored interventions to reduce problem alcohol use among young adults.

Public health relevance
PROJECT NARRATIVE This study will evaluate social media profiles from young adults focusing on alcohol posts describing sobriety, abstinence and moderation (SAM). These social media posts may promote social norms or protective behavioral strategies regarding reduction of alcohol use to other young adult social media users, or SAM posts may indicate intention towards behavior change among individuals who display these messages. We will determine the frequency and meaning of these posts using direct social media observation, surveys to test associations between participants’ SAM posts and alcohol behaviors, and qualitative interviews to understand meaning and intervention possibilities for SAM posts.